Targeting collagen as an interventional approach to improve bone material properties

PROJECT SUMMARY
Mechanical loading and pharmaceutical interventions both improve bone mechanical properties, but there is a
critical gap in our understanding of the role that collagen plays in mediating these effects. This gap in knowledge
by which collagen processing, organization, mineralization, and hydration change with combined load and drug
treatment is a critical impediment to the development of combination therapies that increase fracture resistance
by targeting tissue moieties other than mineral. Our long-term goal is to develop ways to alter physical properties
of bone tissue to increase fracture resistance. The overall objective in this application is to elucidate how
mechanical loading and a RAL-analog (RALA) modify newly forming and pre-existing bone to decrease fragility.
The central hypothesis is that in addition to changes in mass and mineral, collagen-modifying effects exist for
both loading and RALA, the combination of which interactively improve mechanical integrity beyond the effects
of either monotherapy. The premise of this hypothesis stems from preliminary data generated in the applicants'
laboratories. The rationale for the proposed work is that successfully making bone stronger and more resistant
to fracture by combining RALA's hydrating effects with mechanical regulation of bone mass and perilacunar
matrix activity could provide alternative ways for the orthopaedic community to approach the treatment of bone
diseases. Guided by preliminary data, this hypothesis will be tested using three specific aims: 1) to define
influences of loading on osteocyte perilacunar matrix activity and osteoblast matrix deposition; 2) to determine
how RAL/RALA modify collagen quality and matrix hydration; and 3) to determine interactive effects of loading
and RALA. Under the first aim, techniques already in place will be used to investigate in vitro and in vivo loading
effects in healthy cells and animals, as well as in models of disrupted collagen synthesis. In vitro loading will be
induced by substrate stretching for osteoblasts or pulsatile fluid flow for osteocytes. Gene expression of enzymes
and chaperones will be quantified, as well as molecules associated with resorption. Matrix production,
organization, composition and mechanical integrity will be assessed. For in vivo loading experiments, similar
techniques will be used to assess collagen synthesis, post-translational modifications, and crosslinking along
with nanoscale and whole bone tests of mechanical integrity, fatigue resistance and fracture toughness. In Aim
2, outcome measures from Aim 1 will be used to investigate the effects of RAL/RALA as a function of disease
state. In Aim 3, interactive effects of combined loading and drug-based treatment will be assessed. The approach
is innovative because of its focus on collagen, in addition to mass and architecture. It also focuses on osteoblast-
produced collagen on surfaces and changes induced by osteocytes throughout the bone. This work is significant
because it will demonstrate that interactions through combination therapies can improve skeletal mechanical
phenotypes, not by correcting the disease cause, but by impacting collagen synthesis, assembly, mineralization,
and tissue hydration. Such knowledge will provide new ways to approach treatment of fragility-related diseases.

Public health relevance
PROJECT NARRATIVE Mechanical loading and pharmaceutical interventions are both known to improve mechanical properties in healthy and diseased bone. This proposal will test the hypothesis that in addition to mineral and mass, collagen plays a central role in this effect. This proposal is relevant to public health because successfully making diseased bone stronger and more resistant to fracture through alterations to collagen synthesis, quality and mineralization could provide alternative ways for the orthopaedic community to approach the treatment of bone diseases.